Vanderbilt-Nigeria Biostatistics Training Program (VN-BioStat)

PROJECT ABSTRACT
It is critical to build biostatistics capacity in West Africa. Biomedical HIV research is growing in West Africa, but
biostatistical support and expertise are lagging. In collaborative HIV studies between West Africa and U.S.
institutions, the biostatistics leaders are almost always from the U.S. It is important to develop biostatistics
leaders in West Africa – biostatisticians who will not be technicians, but co-investigators, principal
investigators, and thought-leaders in funded HIV/AIDS research. There are several statistics PhD programs in
West Africa, but they often have little or no connection with biomedical research. Funded training initiatives
over the past ten years have been successful at building biostatistics in Southern Africa and East Africa, but no
such programs currently exist in West Africa.
The Vanderbilt-Nigeria Biostatistics Training Program (VN-BioStat) builds on long-standing collaborations
between two leading research institutions in Nigeria and the United States, namely, Aminu Kano Teaching
Hospital (AKTH) and Vanderbilt University Medical Center (Vanderbilt) to establish a research and training
platform for biostatisticians doing HIV-related research in Nigeria. VN-BioStat will build upon the resources of
AKTH and its parent institution, Bayero University in Kano (BUK), to create a cohort of highly skilled Nigerian
biostatisticians with the capacity to lead and supervise biostatistical activities in West Africa. VN-BioStat
leverages the highly successful, collaborative and rapidly expanding portfolio of U.S. National Institutes of
Health (NIH) and other funded research at AKTH, with joint leadership from Vanderbilt investigators. To train
biostatistician leaders in Nigeria, the VN-BioStat program proposes to bring two Nigerian data scientists per
year (total of 10 over 5 years) to Vanderbilt to immerse them in biostatistics and to receive hands on training.
During the one-year training period, trainees will lead the design, analysis, and publication of a collaborative
research project using HIV data from AKTH. They will also lead a related, methodologically focused project
that will culminate in a publication. While at Vanderbilt, they will interact with a team of HIV biostatisticians,
take appropriate biostatistics courses (up to 8 credit hours per semester for 2 semesters), attend biostatistics
and global health seminars, participate in a grant-writing workshop, attend biostatistics clinics, and collaborate
with other Nigerian investigators. They will receive mentorship from Vanderbilt faculty (one biostatistician and
one clinical investigator) and AKTH faculty. We will also conduct annual workshops in Nigeria to provide mid-
level biostatistics training for up to 25 HIV researchers. Potential course topics include methods to address
missing data, introduction to causal inference, regression modeling strategies, big data in biomedical research,
and survival analysis.

Public health relevance
NARRATIVE As Africa’s most populous country, Nigeria is facing the threats of high HIV burden, low combination antiretroviral treatment (ART) coverage, and slow decline in new HIV infections. The need to develop research capacity to generate evidence to tackle the burden of HIV in Nigeria is great, and biostatistics expertise and leadership, which is lagging in West Africa, is critical to these research activities. In response to this need, the Vanderbilt- Nigeria Biostatistics Research Training Program (VN-BioStat) harnesses the longstanding and highly successful research partnership between Aminu Kano Teaching Hospital, Bayero University Kano, and the Vanderbilt Institute for Global Health to establish a research and training platform that will create a cohort of highly skilled Nigerian biostatistics leaders with the capacity to lead independent and collaborative research focused on HIV.